Elevating Voices, Addressing Depression, Toxic Stress and Equity in Group Prenatal Care (EleVATE GC)

Project Summary
Although 21% of pregnant women experience perinatal mood and anxiety disorders, the burden is especially
heavy for low-income and minority women. For example, African-American women have a higher risk of
psychosocial stress (e.g., exposure to adversity, racism, and traumatic life events) throughout life than white
women. Moreover, African-American women are at significantly higher risk for maternal and neonatal adverse
events resulting from psychological distress, such as preterm birth (17% vs. 10%) and low birthweight (13%
vs. 7%). However, African-American women are the least likely group to receive mental health interventions
that could reduce these disparate outcomes. A cross-system collaboration between researchers, clinicians,
and patients is working to overcome these barriers by developing, testing, and implementing a novel model:
Elevating Voices, Addressing Depression, Toxic Stress and Equity in Group Prenatal Care (EleVATE GC).
EleVATE GC is based on group prenatal care and has embedded within it a trauma-informed, evidence-based
behavioral health intervention grounded in anti-oppressive principles. The objectives of this proposal are to
rigorously assess the effectiveness of EleVATE GC and to determine the feasibility, sustainability, and barriers
to implementing EleVATE GC in real-world care settings. These objectives will be achieved by conducting a
pragmatic effectiveness-implementation randomized controlled trial comparing EleVATE GC (n=563) to
individual prenatal care (n=282) for pregnant women at high risk for depression. This trial will be conducted at
eight diverse prenatal clinics in the St. Louis region that serve a population with a high preterm birth rate
(~16% vs. 11% nationally). Additionally, 80% of women served by these sites have a history of depression,
anxiety, trauma, or another mental health diagnosis. Within this trial, Aim 1 is to determine the effectiveness of
EleVATE GC to reduce perinatal depression and adverse pregnancy outcomes among low-income,
predominantly African-American women. This aim tests the hypothesis that, compared to women receiving
individual care, those in EleVATE GC will have lower perinatal depression (primary) and lower risk of preterm
birth and low birthweight infants (secondary). Aim 2 is to identify strategies and contextual implementation
factors to enhance implementation of EleVATE GC. An adaptation of the Practical Robust Implementation and
Sustainability Model will be used across three of the four domains (intervention design, recipient,
implementation and sustainability) at three levels (prenatal care clinic, clinician, and patient). This project is
directly responsive to the call of RFA-MH-20-400 to "test the effectiveness of strategies for implementation and
sustainable delivery of evidence-based mental health treatments and services to improve mental health
outcomes for underserved populations in under-resourced settings in the United States".

Public health relevance
Project Narrative This study will provide high-quality, representative data on the capacity of Elevating Voices, Addressing Depression, Toxic Stress and Equity in Group Prenatal Care (EleVATE GC) to reduce perintal depression, preterm birth, and low birthweight in African-American women. If findings from this study indicate that EleVATE GC is feasible and effective, this model could be implemented nationwide to help achieve mental and obstetric health parity for low-income women of color in the United States.